Minnesota Postbaccalaureate Research Education Program in Diabetes, Endocrinology and Metabolic Diseases

MN PRIMED is a unique postbaccalaureate program for recent college graduates, offering a two-year intensive
research experience combined with advanced graduate courses. Leveraging UMN's extensive research
expertise in Diabetes, Endocrinology, and Metabolism (DEM), MN PRIMED aims to shape the future
generation of researchers in DEM-related research. Participants are paired with two of the 20 experienced
faculty mentors, known for their DEM-related research leadership and commitment to mentoring trainees. This
sets the stage for independent research projects, academic growth, and publication opportunities. To achieve
MN PRIME’s goal of preparing participants for doctoral programs with a focus on diabetes research, MN
PRIMED doctoral readiness program will employ a multifaceted approach: 1. Providing trainees with
exceptional research experiences to develop laboratory competence and multidisciplinary research skills
regarding DEM. 2. Offering high-quality mentorship, including senior/associate mentors (mentor dyads) to
support trainee and associate mentor development. 3. Assuring a path to graduate program entrance with
application process guidance and guaranteed interviews. 4. Facilitating skill development, such as manuscript
writing and effective communication in science, while also helping trainees navigate the complexities of
graduate school. This administrative supplement will provide four additional postbaccalaureate positions in
Year 2 to enhance peer-to-peer engagement among scholars and increase the number of learners pursuing
careers in medical research focused DEM.

Public health relevance
The Minnesota Postbaccalaureate Readiness in Metabolism, Endocrinology and Diabetes (MN-PRIMED) fills a crucial gap at the University of Minnesota (UMN) by training the next generation of outstanding researchers dedicated to addressing diabetes and its associated health issues. This endeavor is made possible through the collaboration of experienced faculty members known for their excellent mentoring and cutting-edge core facilities, creating an exceptional training program for our participants. The goal of the MN PRIMED program is to help participants build a robust research portfolio, which will facilitate their smooth transition into research-focused doctoral degree (PhD, MD/PhD) programs, thus supporting their success in conducting research related to diabetes, endocrinology, and metabolic diseases.